T-cell Biofactories for targeting interstitial fluid pressure

PROJECT SUMMARY
The focus of this proposal is to develop pressure-sensitive T cells that can activate in response to the high
interstitial fluid pressure (IFP) in many solid tumors and release an engineered enzyme to neutralize its source.
The dense fibrous extracellular matrix (ECM) tissue growth common in many solid tumors presents a physical
barrier to the current standard of care chemotherapies and immunotherapies. It leads to the compressive
stresses that cause high interstitial fluid pressure (IFP) (>100 mmHg) as compared to that within normal
tissues (-4 to -6 mmHg). Together, the ECM barrier and IFP resist the influx of therapeutics into tumor sites.
The ECM also harbors the tumor microenvironment (TME) that causes drug resistance and
immunosuppression. Hence, the challenge is to selectively break down the ECM at the tumor site to enable the
entry of therapeutic cytolytic T cells without affecting the normal connective tissues. Here, the investigators
propose that T cells can be engineered to provide a solution to this challenge by selectively degrading the
ECM. The investigators' long-term goal is to develop new treatments by harnessing the cell's potential to
interact with the in vivo environment and target the underlying mechanisms in the disease pathology. The
objective of this project, toward this long-term goal, is to engineer the T cells to synthesize and release the
ECM degrading enzymes upon sensing increased IFP. To achieve this objective, their strategy is to engineer
the T cells with an artificial cell signaling cascade that upregulates the desired proteins in situ. This work is
supported by their preliminary work on engineering the T cells and use of a new assay to simulate IFP in vitro.
The rationale for this effort is that it will lead to a cellular technology to locally disrupt the tumor ECM and
reduce IFP to assist the influx of antitumor agents for improved treatment outcome. The investigators have
described specific milestones with quantitative metric of success and will use the following parallel aims to
conduct the investigations: Engineering of T cells with pressure-sensitive trigger (Aim 1); Engineering of T cell
for pressure-induced expression of ECM degrading enzyme (Aim 2). This effort is expected to lead to a broad-
spectrum technology that has the potential for high-impact. This is because there is no known molecular
biomarker to target either the ECM or IFP. The proposed approach is innovative because it challenges the
status quo by engineering the T cells to actively traffic to the TME and synthesize an ECM-degrading enzyme
in situ. This will mitigate the IFP and enable perfusion of engineered cytolytic T cells to kill tumor cells; as well
as alter the continuously evolving TME to overcome drug resistance and immunosuppression.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because it will open new horizons in the treatments of solid tumors that quickly develops resistance to the current standard of care therapeutics. The project will direct this technology against pancreatic cancer that is one of the most difficult to treat cancers. This effort is relevant to NCI's mission as this platform can be used to circumvent the degradation of systemically administered enzymes and associated toxicity to healthy tissues; and focus its bioavailability only in the tumor microenvironment.